Social connections preventing suicide ideation during developmental transitions among young sexual minority women

PROJECT SUMMARY
Young lesbian, bisexual, and other women who love women (YLBWLW) are more likely to report considering
and attempting suicide than their heterosexual female peers, or gay/bisexual male peers. However, most
researchers combine lesbians/bisexual women with other sexual minorities, resulting in a paucity of research
specific to YLBWLW, and even fewer have examined potential differences between YLBWLW. Further, within
the scant protective factor research, YLBWLW are severely under-represented, and no studies have examined
relationships between individual identity protective factors or interpersonal social connectedness protective
factors specific to YLBWLW and their suicide risk. Another important area of study in suicide research with
YLBWLW involves understanding how developmental transition periods (e.g., into high school, college, or the
workforce) affect suicide risk since developmental transitions can result in a major loss of social connections
that serve as protective factors against minority stress and suicide ideation. To address gaps in the research,
we will pursue the following specific aims: (1) Examine the moderating effects of individual and interpersonal
sexual identity-specific protective factors on theoretical pathways of risk for suicide ideation among YLBWLW;
(2) Test developmental transition periods as a multi-level moderator within the theoretical model; and (3)
Explore in-depth the effects of changes in social connections over time, especially during transition periods, on
suicide risk. The sample will include a nationwide sample of 780 racially and ethnically diverse YLBWLW aged
14 to 30 recruited through social media platforms. Participants will complete an online survey every three
months over an 18-month period. We will address Aim 1 by performing stratified latent variable moderated
mediation analyses for YLBWLW separately to test and compare the following hypotheses: a) individual
protective factors (identity centrality, authenticity, and affirmation) will moderate the risk relationship of minority
stress on entrapment; and b) interpersonal social connectedness factors (social inclusion/belonging,
lesbian/bisexual community involvement, social support) will moderate (weaken) the risk conferred by
experiences of entrapment on suicide ideation. For Aim 2, we hypothesize that a) compared to those not going
through transitions, those going through a transition will experience increased feelings of stress and
entrapment; and b) social connectedness and positive identity factors will moderate associations between
stress, entrapment, and suicide ideation. Aim 3 will involve conducting individual interviews with a subsample
of 70 participants going through a developmental transition and reporting some suicide ideation to glean
insights into YLBWLW’s experiences of these transitions and aspects of social connection that were most
helpful in reducing their distress. The impact of this research involves identifying modifiable individual identity-
and interpersonal social connectedness-level protective factors that will guide suicide prevention efforts across
different levels of influence to promote mental health and reduce deaths by suicide among YLBWLW.

Public health relevance
PROJECT NARRATIVE This longitudinal study seeks to examine the role of sexual identity-specific individual and interpersonal protective factors as moderators of suicide risk, especially during developmental transition periods (e.g., into high school, college, or the workforce) that may disrupt their existing support networks, among young lesbian, bisexual, and other women who love women (YLBWLW). Participants will include 780 racially and ethnically diverse YLBWLW aged 14 to 30 who complete an online survey every three months over an 18-month period, with a subset of 70 completing an individual interview to explore in-depth the effects of changes in social connections over time, especially during transition periods, on suicide risk. This research will identify modifiable individual identity- and interpersonal social connectedness-level protective factors that will guide suicide prevention efforts across different levels of influence to promote mental health and reduce deaths by suicide among YLBWLW.